AUTONOMIC EFFECTS OF ANGIOTENSIN II RECEPTOR BLOCKAGE IN CHRONIC HEART FAILURE

Autonomic nervous system dysfunction in chronic heart failure contributes to morbidity and mortality. Current therapies do not appear to completely antagonize the pathologic effects of angiotensin II, a neurohormone which contributes to this dysfunction, and whose activity is potentiated by it. We will investigate the manner in which angiotensin receptor blockade may reverse this dysfunction.